Astrocyte-neuron interactions in Rett Syndrome and Fragile X Syndrome

PROJECT SUMMARY
In typical neurodevelopment, astrocytes secrete factors to promote the establishment of healthy synapses and
proper circuit function. In neurodevelopmental disorders, astrocyte protein secretion is aberrant with the potential
to impact neuron morphology, synaptogenesis, and behavior. Rett Syndrome and Fragile X Syndrome are
neurodevelopmental disorders with different genetic etiologies (loss-of-function mutation of MECP2 or FMR1,
respectively) but have overlapping deficits in astrocyte function, neuronal activity, and behavior. While wildtype
astrocytes typically support neuron outgrowth, astrocytes from Rett Syndrome or Fragile X Syndrome models
inhibit neuron outgrowth, suggesting a non-cell autonomous effect through secreted factors. The identify of these
factors is just beginning to be uncovered and how they impact synapse formation, neuron function, and behavior
is largely unknown. To identify astrocyte secreted factors altered in neurodevelopmental disorders, the Allen lab
recently profiled the protein ‘secretome’ of Rett, Fragile X, and Down Syndrome model astrocytes. Astrocyte
secretion of the class 3 semaphorin, Sema3c, is increased in all three disorders suggesting a broader role in
neurodevelopment. Class 3 semaphorins regulate axon guidance and synapse formation, elimination, and
maintenance. This project tests the hypothesis that increased astrocyte Sema3c leads to neuronal and
behavioral deficits in Rett Syndrome and Fragile X Syndrome and that reduction of astrocyte Sema3c will
improve these deficits. Preliminary data indicates that astrocyte Sema3c is inhibitory to neurite outgrowth and
that astrocyte-specific reduction of Sema3c improves visual acuity and anxiety-like behavior in Rett Syndrome.
Aim 1 will test if astrocyte Sema3c reduction can improve synaptic activity and neuron morphology deficits
observed in RTT and provide training in electrophysiological techniques. Aim 2 will identify the neuronal Sema3c
receptor and test if reduction can also ameliorate neuronal and behavioral deficits. Aim 3 tests if astrocyte
Sema3c reduction can also improve Fragile X Syndrome phenotypes. These experiments will inform on the role
of astrocyte-neuron interactions in neurodevelopmental disorders and may indicate that increased astrocyte
Sema3c is a convergent mechanism for nervous system dysregulation across Rett Syndrome and Fragile X
Syndrome. This proposal may provide novel therapeutic targets for neurodevelopmental disorders, noting that
inhibitors of Sema3c are currently being explored clinically for cancer treatments.

Public health relevance
PROJECT NARRATIVE The neurodevelopmental disorders Rett Syndrome and Fragile X Syndrome are characterized by altered synaptic function, neuronal morphology, and behavioral deficits. Historically, neurodevelopmental disorder research has focused on neurons but another brain cell type, astrocytes, are increasingly implicated in these disorders with recent research showing aberrant astrocyte protein secretion of the class 3 semaphorin Sema3c in models of both disorders. This project investigates if reducing astrocyte Sema3c, or its receptor, can improve neuron function and behavior in Rett Syndrome and Fragile X Syndrome, informing on potential novel therapeutic targets.